Synthetic Chronogenetic Gene Circuits for Circadian Cell Therapies

Abstract
The goal of this project will be to combine principles of synthetic biology, tissue engineering, and circadian
biology to generate living stem cell-based implants that can deliver biologic drugs in a prescribed circadian
manner for the treatment of a wide range of disease processes that exhibit diurnal rhythmicity. To engineer
this regulatory system, the core clock gene circuitry of murine induced pluripotent stem cells (iPSCs) will be
engineered to synthesize anti-cytokine biologic drugs. These cells will be used to form tissue-engineered
constructs for in vitro and in vivo testing. The first aim of this project will focus on the creation of synthetic
“chronogenetic” gene circuits with prescribed frequency, phase, and amplitude of biologic drug delivery.
More specifically, cells will be designed to synthesize inhibitors of either interleukin 1 or tumor necrosis factor
alpha. These cells will be engineered into stable cartilage constructs in injectable hydrogel carriers that will be
tested as a therapeutic approach for the treatment of experimental rheumatoid arthritis (RA) in two different
mouse models of this disease. RA is an inflammatory disease that affects approximately 1% of the general
population. Several anti-cytokine biologics are currently in clinical use; however, the continuous
administration of these therapeutics at high level can lead to significant adverse effects. We posit that drug
delivery that aligns with the circadian rhythmicity of peak inflammatory cytokine release will have significantly
improved effectiveness. The efficacy of these approaches will be assessed using clinical, histologic,
molecular, and pain/behavior testing. The creation of such synthetic chronogenetic systems cells provides the
possibility for long-term “chronotherapy”, or timed drug delivery for the treatment of many chronic
inflammatory diseases beyond RA.

Public health relevance
Project Narrative The goals of this project are to combine synthetic biology, circadian biology, and tissue engineering to create therapeutic stem cells that can produce biologic drugs on a timed circadian basis. These cells will be engineered into living tissues that will be implanted in vivo to treat daily flares of inflammation in rheumatoid arthritis.